PATHOGENESIS OF HUMAN PITUITARY ADENOMAS

It is hypothesized that pituitary tumor induction may be related to disordered hypothalamic secretion leading to unrestricted pituitary cell hyperplasia (polyclonal tumor). Alternatively, these tumors may arise from a somatic mutation in a single transformed cell giving rise to a monoclonal tumor. In this study, pituitary tumor tissue is acquired for genetic and histomorphologic studies addressing these two hypotheses.